NIH-ONC Cancer Domain Collab FTE

The purpose of this Intra-Agency Agreement (IAA) is to provide resources including FTE support that enable the National Institutes of Health’s National Cancer Institute (NCI) and the Office of the National Coordinator for Health Information Technology (ONC) to develop standards for the United States Core Data Set for Interoperability (USCDI) and the USCDI+ Cancer domain. ONC’s USCDI+ Cancer Program aims to produce recommendations about the minimum set of data elements required to address the complex oncology diagnoses facing the U.S. patient, researcher, and provider communities.